Huntingtin links inflammasome pathway in Huntington's disease Pathogenesis

Abstract
Huntington's disease (HD) is caused by a CAG repeat expansion in the huntingtin (HTT) gene, leading to the
pathogenic expansion of a polyglutamine tract in the huntingtin protein. The key pathological features include
striatal medium spiny neuronal loss, and the presence of cellular inclusion bodies containing mutant HTT
proteins. There is no disease-modifying treatment for HD. The recent failure of the clinical trial of HTT reduction
approaches indicates the urgent need for development of novel therapeutic modalities. Neuroinflammation has
implications in HD pathogenesis. HD human tissue and mouse models demonstrate activated microglia and
astrocytes and elevated levels of plasma cytokines and chemokines, all potentially contributing to HD pathology.
Inflammasomes are key components of the innate immune response, whose formation is triggered by
substances produced through infections, tissue damage, or other disorders. Inflammasome activation has
implications in neuroinflammation and neurodegeneration. Our pilot studies found that HTT interacts with NLRP3
and activates NLRP3-inflammasome, and that knockdown of NLRP3 protects against mHTT-induced
neurodegeneration in cultured human striatal neurons. These results suggest that HTT/NLRP3-linked
inflammasome pathways may play a critical role in HD pathogenesis. Thus, we propose to test the hypothesis
that mutant HTT interacts with and activates the NLRP3-inflammasome in neurons, thereby resulting in
neurodegeneration and HD pathology, and thus that NLRP3 could be a therapeutic target via 3 aims. Aim 1. We
will characterize the interaction of HTT and NLRP3. Aim 2. We will assess whether mutant HTT activates the
NLRP3-inflammasome in neurons, leading to neurodegeneration. Aim 3. We will evaluate whether
downregulation of the HTT/NLRP3-inflammasome pathway as a novel treatment strategy in HD mouse models.
These studies will elucidate the roles of mHTT and NLRP3 interactions in activation of the inflammasome
pathway and determine how this contributes to the neurodegeneration underlying HD pathogenesis. Our results
may provide novel drug targets and therapeutic strategies for future HD interventions, and may also implicate a
shared mechanism of inflammasome activation for other neuroinflammation-related neurological disorders.

Public health relevance
Narrative Huntington's disease (HD) is caused by a CAG repeat expansion in the huntingtin (HTT) gene, leading to the pathogenic expansion of a polyglutamine tract in the huntingtin protein. We recently discovered that mutant HTT interacts with NLRP3 protein and activates the NLRP3-imflammasome in HD mouse and human brain tissues, suggesting a role for specific neuroinflammasome pathways in HD pathogenesis. We will investigate these pathways, which may provide novel targets for development of disease-modifying therapeutic strategies.